NFCR WEB SITE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The NFCR Web site provides basic information about the NFCR, descriptions of ongoing projecxts, instrument capabilities, publications, and recent news. It is also used to provide information about the Annual Course in Flow Cytometry, including agendas, maps, and registration forms. The Web site also contains information about collaboration and service activities of the NFCR, and an application form to access NFCR facilities.